Core B: Education/Outreach Core

Abstract
Over the last ten years, local under-served and impoverished school systems have increasingly
felt the burden of lack of funding and very limited resources in science education. The School
District of Philadelphia, our city’s schools, currently has tremendous budget cuts that directly
result in under-resourced science classrooms. In addition, attracting the next generation into
science, technology, engineering and math (STEM) careers is a fundamental issue facing
today’s educators. It is because of these barriers throughout a student’s educational career that
the outreach core will build a biological science pipeline for local, under-served high school
youth to gain the research skills to be successful in other rigorous science programs, college
courses, and the workforce. Our outreach core will include the continuation of two successful
outreach projects funded by the P50-HD06817 grant - Project BioEYES, the week-long biology
experiment which occurs in classrooms during the school day with the addition of epigenetic
presentations, and the Penn Academy for Reproductive Sciences (PARS), the Saturday
program at UPenn. In addition, we will expand the outreach core to include a formalized 8-week
summer internship for PARS alumnae in co-Investigators’ laboratories. The result of our
outreach core is a series of science exposures that first target city biology classrooms and then
offer specialized opportunities for high school women who have a genuine interest in science
and research.